A neural population model-based characterization and modulation of neural oscillations underlying cognitive control in healthy and depressed/anxious human subjects

Project Summary
Cognitive control, the ability to withhold a default, prepotent response in favor of a more adaptive choice
is often compromised across mental disorders such as depression and anxiety. Thus, a method for
improving cognitive control could be broadly useful in disorders with few effective treatments.
Successfully resolving conflicts is a form of cognitive control where one must suppress a natural response
to follow a less intuitive rule. Conflict processing evokes theta (4-8 Hz) oscillations in the cingulate and
medial prefrontal cortex (PFC) which can be measured through invasive intracranial EEG (iEEG) as well
as frontal midline scalp EEG. Chronic as well as intermittent short trains of high frequency
capsular/striatal stimulation have been shown to enhance theta oscillations while improving performance
on a conflict task. Furthermore, deep brain stimulation (DBS) of the internal capsule or subthalamic
nucleus and transcranial current stimulation of the lateral PFC all improve performance on cognitive
control tasks. These findings strongly suggest that we can modulate both cognitive control and its neural
signatures by targeting the relevant brain circuits with external electrical stimulation. The goal of this
research proposal is to characterize and model cortical oscillations underlying the conflict resolution
aspect of cognitive control in the healthy and anxious/depressed mental states to inform design of
neuromodulation interventions for restoration towards healthy mental states. We will take three
complimentary approaches to achieve this goal. 1) Using iEEG recorded in epilepsy patients undergoing
invasive monitoring for surgical evaluation, we will determine cortical neural oscillations underlying
cognitive control in the framework of a conflict task. We will also use this to differentiate between normal
and depressed or anxious subjects. 2) We will use a neural population cortical model to simulate and
characterize feasible neural mechanisms underlying PFC and temporal cortical oscillations observed
during conflict processing. We will use a data driven approach for estimating relevant model parameters.
3) We will use the model calibrated to individual subjects to design a cortical electrical stimulation
paradigm to modulate the simulated oscillations towards a desired healthy state. We will then validate
our model by testing model predictions in our human subjects and determine if we can successfully
change both neural signals as well as associated behavior. Together, this will lead to a biophysically
motivated model to simulate neural oscillations underlying conflict processing in healthy and pathological
states and allow us to design stimulation paradigms to modulate them. This will also provide new insight
into targeted neuromodulation, such as cortical stimulation for therapeutic purposes and the knowledge
gained will potentially inform other functional domains compromised in mood/anxiety disorders.

Public health relevance
Project Narrative In this work, we propose to characterize brain oscillations that are disrupted in depressed/anxious human subjects compared to healthy counterparts while performing a cognitive task involving conflict resolution. We will use a biophysically inspired neural population model of the prefrontal and temporal cortical network to determine feasible neural mechanisms underlying such brain signals. We will then use this model to determine cortical electrical stimulation to modulate pathological brain oscillations towards restoration of health and test the model predictions on human subjects while performing the conflict resolution task.